Function of CD1a on Langerhans cells in skin inflammation

Summary
In contrast to conventional T cells that recognize peptides on MHC proteins, CD1 molecules present lipid
antigens to T lymphocytes. The abundant expression of CD1a hallmarks Langerhans cells in the skin, a
subtype of dendritic cell with antigen-presenting functions. CD1a is able to bind and display a broad spectrum
of lipid antigens derived from exogenous sources, such as bacteria, or host origin. The complex immune
system of the skin is critically involved in responses to extrinsic insults like allergens, as well as in autoimmune
diseases, such as psoriasis. However, the in vivo role of CD1a on Langerhans cells remains enigmatic, since
CD1a is expressed in humans but lacking in most animal models.
Our hypothesis is that CD1a on Langerhans cells is critical to control inflammatory skin diseases. We will
support this hypothesis with the following specific aims:
1) Investigate the impact of CD1a on inflammatory skin diseases. To overcome the obstacle of CD1a lacking in
normal experimental animals, we propose to use human CD1a-transgenic mice to study the impact of CD1a on
skin inflammation. In preliminary data, we show that the lipidic substance urushiol from the plant poison ivy
induces severe skin inflammation in a CD1a-dependent fashion. The immune response is driven by CD1a-
expressing Langerhans cells that elicit the generation of CD4 T cells, producing the inflammatory cytokines IL-
17 and IL-22. Based on these findings, we propose to investigate the in vivo functions of CD1a in models of
psoriasis using our CD1a-transgenic system.
2) Elucidate the mechanism of lipid presentation and recognition in skin inflammation. For this purpose, we will
analyze antigen specificity (TCR repertoire) of CD1a-restricted T cells. We plan to generate new tools such as
CD1a tetramers and novel techniques for lipid loading of CD1a molecules. Further, we will develop new kinetic
measurements for binding of lipids to CD1a. Using structural biology, we resolved the crystal structure of the
CD1a/urushiol complex. This forms the basis for subsequent structural studies on the ternary complex between
TCR and lipids presented by CD1a, and will also help to identify dominant lipid antigens in inflammatory skin
diseases.
Finally, we aim to translate our findings to the human system and investigate poison ivy responders and
patients suffering from psoriasis with regard to their T cell responses mediated by CD1a. To conclude, we
propose CD1a as a novel target for future therapeutic strategies against inflammatory skin diseases.

Public health relevance
Narrative Inflammatory skin diseases like psoriasis affect millions of people in the US. However, therapeutic options are limited and often only treat the symptoms and not the cause of disease. In this proposal, we demonstrate the important role of CD1a on Langerhans cells in the generation of skin inflammation. These studies are important since they could lead to CD1a as a novel target for therapy of inflammatory diseases of the skin.